STUDY OF SAFETY AND EFFICACY OF NUTROPIN TO IMPROVE WELL-BEING

This protocol is a prospective, double-blind study of the safety and efficacy of growth hormone therapy to improve physical psychosocial well-being in growth hormone deficient adults. Growth hormone or placebo is administered once daily, and principal endpoints are measurements of body composition, muscle strength and endurance, psychological profiles. This protocol has been initiated during 1993, and 4 patients have been enrolled. No data are available yet.